A New Intervention to Improve Function in Veterans with Anxiety and Depression

Background: Anxiety and depression disorders can be very debilitating and result in substantial disability.
These disorders are extremely common, occurring at rates that exceed other common medical illnesses such
as hypertension, diabetes or asthma. Further, anxiety and depression disorders often co-occur (more the rule
than the exception) and having one diagnosis substantially increases the risk for having the other. The clinical
benefits of an intervention that ameliorates both anxiety and depression-related disability and clinical
symptoms could be critically important, as odds of Veteran suicide completion significantly increase when
depression co-occurs with anxiety disorders. Extensive preclinical and clinical data (from our group and others)
support a novel neurosteroid intervention (pregnenolone/PREG) as a promising new treatment for anxiety and
depression disorders. Furthermore, extensive evidence in rodent models and clinical biomarker candidate
studies suggests substantial analgesic, anxiolytic, sleep and anti-inflammatory actions. PREG also significantly
reduced low back pain in a randomized controlled trial of 94 OEF/OIF/OND-era Veterans compared to placebo,
and allopregnanolone (ALLO) levels are inversely correlated with several commonly co-occurring symptoms,
including sleep disturbance and pain disorders. Restoration of ALLO levels via a precursor loading strategy
with PREG could thus ameliorate ALLO deficits and alleviate multiple functionally impairing and health-related
symptoms. Additionally, PREG has been very well-tolerated in multiple clinical trials and exhibits a very
favorable side effect profile – potentially supporting a superior safety and side effect profile advantage
compared to existing pharmacological interventions. We thus propose to conduct a 10-week double-blind,
randomized, placebo-controlled trial of PREG versus placebo in Veterans with anxiety and depression.
Methods: The primary goal of this proposed project is to conduct a 10-week adaptive, randomized, double-
blind, placebo-controlled trial to evaluate flexibly dosed pregnenolone [to improve functional impairment and
disability associated with anxiety and depression. Following a 2-week placebo-only lead-in period, 84 subjects
will be enrolled and randomly assigned to receive PREG or placebo for 8 weeks (flexible dosing strategy). We
hypothesize that treatment with PREG will significantly reduce functional impairment and disability associated
with anxiety and depression symptoms. Secondary outcomes include diagnostic improvements in anxiety and
depression, pain symptoms and sleep quality. We hypothesize that PREG will improve symptoms of anxiety
and depression, pain and sleep quality. Finally, we will quantify serum neurosteroid levels at baseline and post-
treatment by highly sensitive and specific mass spectrometry-based techniques to determine if PREG and
downstream neurosteroid metabolites such as ALLO are predictors of functional/therapeutic response. We will
also examine proinflammatory markers. We hypothesize that changes in PREG and other neurosteroids (as
well as proinflammatory markers) will predict improvements in mental health and functional outcomes.]
Conclusion: Results from the proposed trial could provide rigorous scientific rationale for future pivotal Phase
3 trials to test PREG for the treatment of anxiety and depression disorders (improving functional outcomes and
mitigation of pain and sleep disturbance). PREG has been very well-tolerated in multiple Veteran cohorts and
could thus be a safe, inexpensive and efficacious new intervention to improve function and multiple behavioral
symptoms.

Public health relevance
Anxiety and depression symptoms occur at high rates in Veteran populations and can significantly impact function, compromising the ability to work and to successfully form and maintain valued relationships. Several other symptoms commonly occur with anxiety and depression, including poor sleep quality and chronic pain. Since all these symptoms frequently occur together, they may have a common underlying biological basis. A single medication that could effectively treat all these symptoms would be ideal. Converging data suggest that pregnenolone is a promising pharmacological agent for treating multiple psychiatric symptoms and functional impairment. We thus propose to conduct a clinical trial of pregnenolone in Veterans with anxiety and depression symptoms. Pregnenolone has minimal side effects, and our prior research demonstrates that pregnenolone is well-tolerated by Veterans. Treatment with pregnenolone could thus be an efficacious new therapeutic for Veterans experiencing depression, anxiety, poor sleep quality and chronic pain conditions.